ASYMPTOMATIC CARDIAC ISCHEMIA PILOT STUDY

To determine the relative efficacy of symptom (angina) directed therapy, angina guided plus ambulatory electrocardiogram guided medical therapy and mechanical revascularization to provide freedom from myocardial ischemia.